Training Program in Investigative Hepatology

PROJECT SUMMARY
This proposal is a competitive renewal application for five years of support to continue the 45-year-old Yale
Postdoctoral Training Program in Investigative Hepatology. The goal of this training program is to provide basic
laboratory, translational, or clinical research training for physicians who have completed clinical training in
gastroenterology in preparation for careers as independent investigators in academic hepatology and to provide
research training for recent PhD graduates to prepare them for careers as independent investigators in basic
liver-related research. The program draws on the exceptional liver research environment at Yale, including a
large pool of preceptors who are internationally recognized investigators that are well funded and have extensive
mentorship experience. The program’s trainees in turn have a long track record of going on to become leaders
in the field of hepatology; in recent years most trainees have obtained independent funding, and nearly all have
published multiple papers related to their training and have gone on to academic or other research-intensive
careers. The program will continue to train four postdoctoral fellows at a time, and individual trainees will be
supported for two to three years. Selection of trainees will be based on strong prior research experience and
commitment to liver-related research. This training program will use the combined resources of the NIDDK-
funded Yale Liver Center, the Yale Digestive Diseases Section, and facilities of the participating faculty including
the Departments of Internal Medicine, Cell Biology, Cellular and Molecular Physiology, Human Genetics,
Immunobiology, and Pharmacology. The major research areas represented include (1) liver immunobiology and
inflammation, (2) hepatic metabolism, and (3) epithelial biology and pathobiology. The Section of Digestive
Diseases, the Medical School's Investigative Medicine Program as well as enrichment programs provided by the
Liver Center together provide a strong and liver-oriented educational curriculum. Trainees are encouraged to
audit or enroll in specific courses in the School of Medicine or the School of Public Health, attend annual
laboratory and lecture courses designed for physician trainees in the Department of Medicine, and are required
to attend both Hepatology and Basic Science Journal Clubs, plus weekly research and pathophysiology
seminars. Progress is monitored through several mechanisms including "Research in Progress" seminars and
individual Progress Committees.

Public health relevance
PROJECT NARRATIVE Liver disease affects nearly one in three Americans and a billion people worldwide. The purpose of this grant is to provide training to physicians and other scientists to pursue basic, translational and clinical research into the causes of the various forms of liver disease and to develop new and more effective treatments.